Dietary fructose and NASH/HCC progression

PROJECT SUMMARY
“Dietary fructose and NASH/HCC progression”
Nonalcoholic fatty liver disease (NAFLD)/nonalcoholic steatohepatitis (NASH) is emerging as a leading
risk factor driving the development of hepatocellular carcinoma (HCC). Dietary fructose is a major risk factor for
NAFLD and subsequent HCC progression. Fructose is primarily metabolized by ketohexokinase (KHK) and KHK-
deficient mice or pharmacologic inhibition is protective against NAFLD but the underlying mechanisms
responsible are largely unexplored. We recently designed studies to investigate whether loss or inhibition of KHK
impacts HIF-α protein stabilization by crossing HIF stabilization reporter (ODD-luc) mice with KHK-/- mice
discovered that intestinal HIF-stabilization (as measured by luciferase activity) is significantly and consistently
reduced by KHK-deficiency. Interestingly, reduced HIF-α stability in KHK-/- mice is fully rescued by the small
molecule inhibitor of pyruvate kinase M2 (PKM2) suggesting that fructose/KHK-dependent HIF-α stabilization
may be mediated by the PKM2 inhibitory metabolite, F1P. Consistent with the reduced HIF-α stabilization
observed in KHK-deficient mice, intestinal expression of the HIF-2α-induced iron transporter, DMT1, is reduced
in KHK-/- mice consistent with our observations that KHK-deficient mice exhibit spontaneous systemic iron
deficiency. Because plasma iron is essential for maximal neutropoiesis coupled with the fact that KHK-deficiency
also results in markedly reduced neutrophil numbers and percentages, our overarching hypothesis is that
fructose facilitates increased intestinal iron absorption via a KHK/F1P/HIF-2α axis, leading to pro-inflammatory
neutropoiesis that, in turn, contributes to the development of HCC. We will test this hypothesis using the following
two specific aims: Aim 1. Determine whether dietary fructose promotes intestinal iron absorption in a KHK, F1P
and HIF-2α-dependent manner. Aim 2. Determine whether dietary fructose promotes systemic inflammation
leading to pro-tumorigenic liver microenvironments due to increased iron-dependent neutropoiesis.

Public health relevance
NARRATIVE “Dietary fructose and NASH/HCC progression” The rapid rise of nonalcoholic fatty liver disease (NAFLD)/nonalcoholic steatohepatitis (NASH) has correlated with has a corresponding increase in the prevalence of hepatocellular carcinoma (HCC). Dietary fructose is thought to be a major risk factor for NASH→HCC progression but the mechanisms linking dietary fructose to inflammation-dependent HCC progression are entirely unknown. This project seeks to investigate a highly novel mechanistic pathway that links dietary fructose consumption to inflammation-dependent HCC progression and will explore novel therapeutic approaches with which to target.